Deprescribing of Disease Modifying Agents in Older Adults with Multiple Sclerosis

PROJECT SUMMARY/ABSTRACT
Disease Modifying Agents (DMAs) are vital for reducing inflammation and limiting disease activity in multiple
sclerosis (MS). However, there is a decline in inflammation and disease activity in older adults with MS due to
natural disease progression. In fact, most patients with MS over age 65 have very limited disease activity and
relapses. DMAs are not effective in preventing disability and disease progression associated with aging. There
is also very limited data on the effectiveness of DMAs in older adults with MS. Also, DMA use is associated with
increased infections, malignancy, and other adverse events. Continued DMA use in older adults is highly debated
due to no proven efficacy, safety concerns, and high prescription costs. Therefore, there is an urgent need to
evaluate the benefits and safety of DMA discontinuation in older adults. Although some studies with limited
samples found preliminary evidence for DMA discontinuation, no large-scale pharmacoepidemiological study
evaluated both the safety and effectiveness of DMA deprescribing in older adults. Our previous based study
found that older adults with MS received injectables (55%), followed by orals (32%). However, over 35% of older
adults discontinued their DMAs after 12 months. The overall goal of this research is to evaluate deprescribing
and associated effectiveness and safety outcomes in older adults with MS. The specific objectives of the
research are to: (1) examine DMA use and deprescribing in older adults with MS; (2) evaluate the effect of DMA
deprescribing on relapse rates and frailty; and (3) evaluate the effect of DMA deprescribing on serious infections
and all-cause mortality in older adults with MS. This study will involve a longitudinal national cohort of older adults
over 65 years of age with MS and DMA use based on ten-year Medicare claims data involving Parts A, B, and
D. The study will test the hypotheses that (i) there is no difference in relapse rates and frailty in older adults who
are deprescribed and those who continue DMA, (ii) and DMA deprescribing is associated with decreased
infection rates and all-cause mortality in older adults with MS. Deprescribing will be defined as the
discontinuation of DMAs for at least 12 months with a one-year baseline adherence of DMAs (proportion of days
covered of >0.80). The comparator group will be those continuing their DMAs. The relapse rates and frailty will
be operationalized using validated claims-based algorithms. The risk of serious infections and specific types of
infection, along with mortality, will also be evaluated. The study will involve a propensity score-matched cohort
design based on generalized boosted models to adjust for the selection bias within the multivariate context of
the Andersen Behavioral Model. Multivariable models within propensity score-matched sets will be used to
evaluate the effectiveness and safety outcomes. Multiple sensitivity analyses involving differing analytical
considerations will be conducted to assess the robustness of the findings. This will be the first national study to
provide valuable real-world evidence regarding DMA deprescribing and associated outcomes with significant
clinical and policy implications for improving prescribing practices and quality of care in older adults with MS.

Public health relevance
PROJECT NARRATIVE Disease Modifying Agents (DMAs) are not effective in older adults for preventing disability and disease progression associated with aging. Therefore, the goal of this research is to evaluate deprescribing and the associated effectiveness and safety outcomes in older adults with MS. This will be the first national study to provide valuable real-world evidence regarding DMA deprescribing and the associated outcomes with significant clinical and policy implications for improving prescribing practices and quality of care in older adults with MS.